Texas Developmental Center for AIDS Research

PROJECT SUMMARY – TEXAS DEVELOPMENTAL CENTER FOR AIDS RESEARCH
In 2019, the US announced a plan to End the HIV Epidemic by 2030. To be successful, strategies that improve
HIV prevention and HIV treatment outcomes are needed. Only 56% of people with HIV (PWH) were virally
suppressed in 2018, a critical determinant of health outcomes and transmission risk, and 51% of HIV
diagnoses in 2018 were in the US South, despite constituting only 38% of the population in the US. Texas is
the second most populous state in the US, behind California, with about 29 million residents, and is in the US
South as defined by CDC and the Census Bureau. Unfortunately, this large Texas population, coupled with
weaker public health and prevention policies and funding across the US South, has a growing HIV population
that lags in critical health outcomes. There is an urgent need for more research and research infrastructure to
combat the HIV epidemic in the US South and specifically in Texas to both contribute to ending the US HIV
epidemic and to learn how to best do that in resource constrained areas of the US. We therefore will establish
a Texas Developmental Center for AIDS Research (D-CFAR) to support the overall mission of the national
CFAR program by facilitating high-priority HIV research and supporting the effort to end the HIV epidemic in
the US. Three institutions have collaborated to propose this D-CFAR: Baylor College of Medicine in Houston,
The University of Texas Health Science Center at Houston and the Texas Biomedical Research Institute in
San Antonio. Based upon the outstanding expertise of its investigators, the Texas D-CFAR will focus its
activities in the five-year funding period on the research theme “Ending HIV and Optimizing HIV Health in
Texas.” To accomplish its goals, the Texas D-CFAR will: 1) Provide organizational and financial management
and facilitate activities and programs that strengthen and enrich the D-CFAR research and intellectual
environment; 2) Support targeted high-priority interdisciplinary pilot research projects, assist in responding to
new HIV-related research initiatives, and facilitate research on ending HIV and improving health of PWH in
Texas; and 3) Provide state-of-the-art expertise, advice, and services to facilitate the range of HIV-related
research for D-CFAR investigators. The Texas D-CFAR will support an Administrative Core, a Developmental
Core, a Basic Science Core and a Clinical and Biostatistics Core to meet investigator needs and catalyze
innovative research. The scientific Cores will build on outstanding strengths in virology, non-human primate
resources, clinical trials research and biostatistics. The D-CFAR will engage a Community Advisory Board and
Internal and External Advisory Boards for guidance. Coupled with outstanding institutional support, the D-
CFAR will stimulate new research and collaborations among basic, translational, clinical, health services and
public health researchers. The D-CFAR will significantly advance knowledge needed to end HIV and improve
the health of PWH in Texas and similar areas, train the next generation of scientists, and grow into a full
CFAR, thereby contributing to ending the HIV epidemic in Texas, the US South, and beyond.

Public health relevance
PROJECT NARRATIVE The Texas Developmental Center for AIDS Research (Texas D-CFAR) will facilitate collaborative and multidisciplinary HIV research. The Texas D-CFAR will align with NIH HIV research priorities to foster synergy, promote efficiency, and support coordinated research between its home institutions - Baylor College of Medicine (Houston), University of Texas Health Science Center at Houston, and the Texas Biomedical Research Institute (San Antonio). The Texas D-CFAR will build research capacity to achieve its goal: End HIV and Optimizing Health in Texas.